Positive Emotion in Bipolar Disorder Onset and Illness Course in Emerging Adults

PROJECT SUMMARY
Those at-risk for BD and diagnosed with BD demonstrate significant positive emotion dysregulation (PED), and
that PED is related to the severity of illness, functional outcomes, and comorbid conditions. Evidence strongly
suggests that PED is central in BD and predicts maladaptive risk-taking behaviors, placing it as a top NIMH
priority. PIs Gruber, Johnson and others have provided robust empirical support for PED in at-risk and clinically
diagnosed BD populations over 15 years, including dozens of laboratory studies. Prior work, though, has not
established whether PED predicts the onset of BD, nor the progression of symptoms during early phases of the
disorder. This project will use multi-modal behavioral and neuroimaging approach to provide evidence of the
import of PED to BD risk across three groups over a longitudinal 24-month period, including emerging adults
with early onset of BD disorder, those at high risk but not yet diagnosed with BD, and those at low risk for BD.
Of import, we will conduct novel work to examine how PED can predict initial onset of BD among emerging
adults and can predict the course of BD among the high risk and the early onset groups. We will focus on
emerging adults as the age group with the highest risk of mood onset and functioning difficulties. We will recruit
a large, diverse community sample, and we will identify those at high and low risk for BD using a well-validated
risk indicator, and we will use diagnostic interviews to assess BD diagnoses. Participants in all three groups
will complete a multi-modal laboratory assessment of PED, including behavioral and neural indices. We will
test the predictive value of these processes across a 24-month longitudinal follow-up of the high-risk group and
the early onset group. Accordingly, this proposal has three specific aims: Aim 1: PED and Behavioral
Mechanisms: Extend well-established behavioral findings of elevated PED in the BD early-onset > BD high-
risk > BD low-risk groups. AIM 2: PED and Neural Mechanisms: Employ a well-validated fMRI task to assess
dynamic neural processes associated with positive emotion reactivity and emotion regulation, to show (a)
greater magnitude of neural signature for emotion reactivity (b) diminished magnitude of neural signature for
emotion regulation, and (c) and diminished task-based functional connectivity between the PFC and parietal
regions during emotion regulation across the early-onset BD, high-risk BD and low-risk BD groups. AIM 3. PED
and Associations with BD Onset and Illness Course: Establish the predictive value of PED-relevant
behavioral and neural processes predict onset of BD in the high-risk group and predict mania symptom
severity in the BD high-risk and BD early-onset groups across a 24-month longitudinal period. This project fits
with NIMH goals of integrating basic research with clinical science to enhance outcomes for those with mental
illness.

Public health relevance
PROJECT NARRATIVE Those at-risk for bipolar disorder and those diagnosed with the disorder demonstrate significant positive emotion dysregulation (PED), and PED is related to the severity of illness, functional outcomes, and comorbid conditions. This project will use multi-method experimental behavioral and neuroimaging paradigms to examine PED among three emerging adult groups: (1) early-onset bipolar disorder diagnosis, (2) at high-risk for bipolar disorder but not yet diagnosed, and (3) at low-risk for bipolar disorder. Of import, we will conduct novel work to examine how PED can prospectively predict the onset and progression of bipolar mood symptoms across a two-year longitudinal follow-up within the early-onset and high-risk groups to predict the early onset and progression of symptoms, so as to foster development of future interventions.